Delineate the Role of GSTP1 in Advanced Prostate Cancer

PROJECT SUMMARY/ABSTRACT
Prostate cancer is the second leading cause of cancer associated deaths in men in the United States. The first
line of treatment for men with advanced metastatic prostate cancer is hormone therapy. Although initial
responses are observed, unfortunately, the disease commonly recurs in its aggressive hormone therapy-
resistant form, which is largely responsible for prostate cancer-specific mortality. Thus, there is an urgent need
to define the mechanisms that drive the aggressive disease and develop novel strategies to overcome advanced
treatment-resistant prostate cancer.
We have recently shown that GSTP1 protein is significantly upregulated in treatment-resistant prostate cancer.
We have strong preliminary evidence suggesting that GSTP1 may play functional role in driving aggressive
prostate cancer and may represent a promising therapeutic target for the advanced disease. We have recently
demonstrated that GSTP1 is significantly elevated in hormone therapy-resistant prostate cancer and that
inhibition of GSTP1 suppresses prostate cancer growth.
The main goals of the proposed project are:
1) test the functional role of GSTP1 in advanced prostate cancer.
2) test the therapeutic potential of GSTP1 inhibition alone and in combination with cisplatin in aggressive
prostate cancer in pre-clinical settings utilizing patient-derived xenograft (PDX) models of NEPC.
3) Delineate the mechanism of action of GSTP1 in advanced prostate cancer.
Successful completion of the proposed research will lead to: 1) defining the role of GSTP1 in aggressive therapy-
resistant prostate cancer and 2) direct new strategies regarding novel therapeutic interventions to combat the
deadly form of the disease.

Public health relevance
PROJECT NARRATIVE The major goal of the proposed project is to test the role of GSTP1 in aggressive prostate cancer. The study will also define novel mechanisms through which GSTP1 contributes to the development of the advanced disease. Completion of the proposed research will give us insights into new mechanisms underlying the development of aggressive prostate cancer and open novel avenues for therapeutic interventions.